Adding Bright Light Treatment to Cognitive-Behavioral Therapy for Insomnia to Prevent Chronic Post-Surgical Pain in Older Adults

Preventing Chronic Postsurgical Pain (CPSP) and reducing postsurgical opioid exposure is a public health
imperative. Perioperative insomnia is an increasingly recognized modifiable risk factor for CPSP and opioid
usage, but studies have yet to evaluate whether treating insomnia perioperatively reduces CPSP and opioid
exposure. Insomnia has been linked to central nervous system alterations that contribute to the transition from
acute to chronic pain and is prevalent in at least 50% of older adults with knee osteoarthritis (KOA), awaiting
total knee arthroplasty (TKA). Currently, TKA for end stage KOA is the most common elective surgical
procedure in the US. Rates of CPSP after TKA are high with ~ 20% of individuals reporting moderate to severe
CPSP. Research determining whether optimizing sleep improves TKA outcomes is critical because TKAs are
estimated to increase exponentially to 3.5 million per annum in the next decade. Benzodiazepine receptor
agonists, the most commonly used therapies for insomnia are contraindicated in older adults and especially
dangerous in the context of opioid pain management. Cognitive-behavioral therapy for insomnia (CBTi), is a
safe, well-established treatment for insomnia that improves sleep in chronic pain and has demonstrated small,
but significant effects on pain severity that require enhancement. Emerging data suggests that morning bright
light treatment (MBLT) not only improves circadian rhythms and sleep, it has mood enhancing and analgesic
properties. Although both CBTi and MBLT have distinct mechanisms of action, research on their combination is
just emerging and neither has been used to prevent CPSP or reduce opioid use. We propose a randomized,
controlled, parallel arm, clinical trial, to test the effects of CBTi and CBTi+MBLT on CPSP and opioid sparing
following TKA. Five weeks prior to surgery, TKA patients with insomnia will be randomized to one of 3
conditions matched on timing and contact duration: 1) CBTi+placebo [four pre-surgical telehealth sessions +
two post-TKA boosters (2-week and 3 mo. post TKA)] with 1-hour daily morning deactivated ion generator
sham exposure (placebo) for 4-wks. pre and 4-wks. post-surgery; 2) CBTi+MBLT (1-hour daily morning bright
light treatment for 4-wks. pre and 4-wks. post-surgery), and 3) Education (EDU)+placebo with 1-hour daily
morning deactivated ion generator exposure (4-wks. pre and 4-wks. post-surgery). Outcomes will be assessed
at baseline, post CBT-I (pre-surgery), 6-weeks, 3, and 6-months post-surgery. We have three aims: 1) To
evaluate the effects of perioperative CBTi+placebo and CBTi+MBLT on CPSP [(3-6 mos.) primary] and opioid
use [(6 weeks-6 mos.) 2ndry]; 2) To examine the effects of CBTi+placebo and CBTi+MBLT on pre-surgical,
acute post-surgical (6-weeks), and chronic (3, 6 months) insomnia symptom severity, circadian rest activity
rhythm (RAR), and depressed mood; 3) (exploratory) Evaluate whether the effects of treatment condition on
CPSP and opioid use from 3 to 6 months post-TKA are partially mediated by improvements in insomnia
severity, increases in circadian RAR strength and decreases in depressed mood at 6-weeks post-TKA.

Public health relevance
Narrative Total Knee Arthroplasty (TKA) is the most common elective surgical procedure in the US with up to 40% of patients reporting some degree of chronic post-surgical pain and 13% of opioid naïve patients continuing use of opioids 1-year after surgery. Insomnia impacts 50% of TKA patients and is increasingly identified as a perioperative risk factor for chronic post-surgical pain and opioid misuse, but it is not known whether treating insomnia perioperatively reduces chronic post-surgical pain and opioid consumption. This randomized controlled trial in patients undergoing TKA, tests the effects of perioperative cognitive-behavioral therapy for insomnia (CBTi) and CBTi + morning bright light treatment on chronic post-surgical pain and opioid consumption.